Recruitment and Engagement in Care to Impact Practice Enhancement (RECIPE) for Sickle Cell disease

PROJECT ABSTRACT
The Recruitment and Engagement in Care to Impact Practice Enhancement (RECIPE) project has a goal
to reduce the science-to-practice gap in sickle cell disease (SCD) by identifying individuals who are not receiving
guideline based SCD care. Up to 50% of affected adults may not see SCD specialists, which limits the delivery
of disease-specific screenings and treatment with disease modifying therapies. Issues are worsened for
individuals living in rural regions or with socio-economic challenges known to accentuate health disparities. This
team of investigators has been working to address this problem since the inception of the NHLBI-funded Sickle
Cell Disease Implementation Consortium (SCDIC). In our previous studies, we identified a need to optimize
research methodologies to engage individuals in evidence-based SCD care and established foundational terms
through a Delphi consensus process, for “unaffiliated patients with SCD” and “SCD specialist”. The current
project, RECIPE, will advance these efforts to identify and link unaffiliated patients to SCD specialists by applying
implementation science research to adapt existing methods used in human immunodeficiency virus (HIV) care.
Similar to SCD, individuals with HIV have faced significant healthcare scrutiny causing reciprocal misgivings
about healthcare. In this project, we will adapt models for patient identification and engagement in HIV to SCD
using a multi-staged, patient-oriented process. We embed this work in the Interactive Systems Framework for
Dissemination and Implementation to ensure high quality implementation and evaluation in each stage of the
affiliation process, with emphasis on the readiness of health systems to serve traditionally underserved
populations and sustainability of this work in these areas.

Public health relevance
PROJECT NARRATIVE There is a science-to-practice gap in sickle cell disease (SCD) between evidence-based guidelines and the care that is delivered. Issues are worsened for individuals living in rural regions or with socio-economic challenges known to accentuate health disparities. The current project, Recruitment and Engagement in Care to Impact Practice Enhancement (RECIPE) will advance efforts to identify and link unaffiliated patients to SCD specialists by applying implementation science research to adapt existing methods used in human immunodeficiency virus (HIV) care.